Mitochondrial fission proteins shape platelet production and function

Abstract
Mitochondrial dysfunction is associated with numerous diseases, including disorders of thrombosis and
hemostasis. While platelets inherit fully functional mitochondria from megakaryocytes, the mechanisms for
preserving mitochondrial integrity during megakaryocyte development and their loading into platelets are not
clear. Genetic studies have linked the mitochondrial fission protein Dynamin Related Protein 1 (DRP1) with
platelet counts, size, and functional responses in diverse populations. Our preliminary data show that loss of
DRP1 in human and mouse megakaryocytes profoundly reshapes mitochondrial morphology in
megakaryocytes, culminating in platelets loaded with excessive and massive mitochondria. Platelet size was
significantly increased, and platelet counts decreased, mirroring human association studies. Moreover, platelet
functional responses were also compromised, pointing to a role for mitochondrial fission in multiple aspects of
megakaryocyte and platelet biology.
In Aim 1 we propose that basal DRP1-mediated fission maintains mitochondrial integrity during
megakaryocyte development, while heightened fission at proplatelet production reshapes mitochondria for
loading into proplatelets and subsequent platelet release. Aim 2 seeks to elucidate how loss of DRP1 and
other fission proteins alters platelet function, hemostasis, and thrombosis through mitochondrial and non-
mitochondrial mechanisms. These aims integrate mouse models and human studies, including
platelet/megakaryocyte specific DRP1/FIS1 knockouts, newly developed DRP1 inhibitors, and CRISPR edited
primary CD34+ cell derived megakaryocytes. Aim 3 employs a novel high-throughput CRISPR functional assay
to comprehensively evaluate the impact of all known genes in the mitochondrial fusion/fission pathways on
platelet-like functional responses in megakaryocytes.
This research is pivotal and innovative: we will examine mitochondrial fission, a novel pathway regulating
loading of mitochondria into platelets to modulate platelet size and function. Our studies will shed light on why
human DRP1 variants are associated with platelets phenotypes and determine how DRP1 and other proteins
involved in mitochondrial fission/fusion affect platelet function. The results may lead to new approaches to
target thrombotic disorders and enhance platelet production, leveraging a molecular target with existing
inhibitors already undergoing preclinical trials for a variety of other diseases.

Public health relevance
Project Narrative Heart attacks and strokes are caused when blood clots caused by cells called platelets stop blood flow. Mitochondria supply cells with energy and are maintained by proteins that balance mitochondrial division and fusion, including in platelets and the cells that form platelets. Our goals are to define how mitochondrial fission proteins contribute to platelet numbers, size, and function, and whether this pathway can be targeted to reduce cardiovascular disease.